Inhibition of central CO2 chemoreception by seizures: Effects on ventilation, cardiovascular control and postictal recovery of consciousness

Sudden unexpected death in epilepsy (SUDEP) is the leading cause of death in patients with refractory
epilepsy and is two to four times as common as sudden infant death syndrome (SIDS). Because the
mechanisms responsible for SUDEP have not been clearly defined, there are no specific treatments to prevent
it. Observations from human and animal studies indicate that seizure-induced respiratory arrest typically
precedes asystole, and that many patients experience varying degrees of respiratory depression, autonomic
dysfunction, and impaired arousal following seizures. There is a fundamental gap in understanding how
seizures do this, and why only a small fraction of seizures lead to death. Serotonin (5-HT) neurons are central
CO2 chemoreceptors (CCR) that regulate breathing, autonomic function, and arousal. Patients with low
interictal CCR are more hypercapnic following a generalized tonic-clonic seizure (GTCS), and seizures may
depress CCR, an effect that can be measured with the hypercapnic ventilatory response (HCVR) test.
Impairment of CCR by seizures may contribute to autonomic dysfunction and impaired arousal after GTCS,
increasing the risk of SUDEP. The long-term goal is to develop new treatments to prevent SUDEP by
elucidating the mechanisms responsible for seizure-induced respiratory depression, autonomic dysfunction,
and impaired arousal. This knowledge will also lead to novel biomarkers to identify patients at highest risk. The
objective here is to characterize the relationship between seizure-induced blunting of CCR and postictal
respiratory depression, autonomic dysfunction, and impaired arousal. The central hypothesis is that seizures
inhibit 5-HT neurons in a subset of patients, and this leads to impairment of the ability to detect hypercapnia
and to initiate respiratory, autonomic and arousal responses to restore blood gas homeostasis. This hypothesis
has been formulated based on human and animal data from the applicants’ own laboratories and will be tested
with the following Specific Aims. (1) Characterize the role of CCR in postictal respiratory control and the acute
effect of seizures on CCR. (2) Determine how CO2 affects interictal autonomic function and how this is altered
by seizures. (3) Determine whether seizures impair the ability of CO2 to hasten recovery of consciousness in
the postictal state. Patients admitted to the epilepsy monitoring unit for video EEG study will undergo HCVR
testing during the interictal period and several times after seizures to determine the time course of impaired
CCR and its effect on cardiorespiratory and autonomic function. We will also measure the effect of CO2 on
arousal from sleep and on recovery of consciousness after GTCS, and relate these measures to CCR. This
approach is innovative because it is the first to directly examine how inhibition of serotonin neuron function by
seizures affects the respiratory, autonomic, and arousal response to CO2. The proposed research is significant
because identifying these mechanisms may lead to novel treatments to prevent SUDEP.

Public health relevance
Sudden unexpected death in epilepsy (SUDEP) is the leading cause of death in patients with refractory epilepsy and is two to four times as common as sudden infant death syndrome (SIDS). Inhibition of serotonin neurons by seizures may impair the body’s ability to regulate breathing, autonomic function, and arousal during a vulnerable period. The proposed research is relevant to public health and the NIH’s mission because a better understanding of how inhibition of CO2 chemoreception by seizures causes respiratory depression, autonomic dysfunction, and impaired arousal is expected to lead to the identification of novel candidate biomarkers for SUDEP risk and to the development of new preventive treatments for SUDEP.